CIBBR Administrative Core

PROJECT SUMMARY (ADMINISTRATIVE CORE)
The environment for conducting biomedical and bioengineering research at the University of New
Hampshire has substantially improved upon implementation of the Phase 1 COBRE: Center of Integrated
Biomedical and Bioengineering Research (CIBBR). To build upon these accomplishments and to further
improve the effectiveness of the administration of CIBBR, the objectives of the Administrative Core during
Phase 2 are to (1) enhance the highly effective administration of CIBBR, including programming offered to
CIBBR investigators and its evaluation model; (2) help recruit and support early-stage and senior-level tenure-
track faculty as a cluster hire that is thematically focused on quantitative/computational biology and multi-
omics; (3) enhance our multi-faceted Mentoring Program; and (4) strengthen the CIBBR ecosystem by
expansion of its Research Cores and by outreach activities to other regional IDeA programs. We will attain
these Administrative Core objectives by (1) enhancing the administrative operations of CIBBR and its
programs, in part through the recruitment of two senior-level biomedical and bioengineering researchers; (2)
recruiting new early-stage investigators supported by the CIBBR Mentoring Program, thereby attaining a
critical mass of successful biomedical and bioengineering researchers; and (3) growing the CIBBR ecosystem
through expansion of its Research Cores and coordination of outreach activities with regional IDeA programs
and external partners.
Upon completion of these aims, CIBBR will have heightened its impact on the biomedical and
bioengineering research environment at UNH by increasing the number of faculty at UNH conducting NIH-
funded research, advancing the career development of early-stage faculty, and facilitating the pathway from
basic biomedical research to clinical/translational research and commercialization in order to expedite the
development of treatments for human diseases.